Analysis of non-canonical functions of microRNAs

SEE RESEARCH STRATEGY

Public health relevance
AWARDED NARRATIVE This project aims to uncover how a particular small RNA blocks the main processing route of the competing small RNAs to favor red blood cell development. These results will help to understand diseases like anemia.